Proteomics Core Facility

Proteomics Core Facility The Proteomics Core strives to provide outstanding mass spectrometry-based service and training to Cancer Center researchers. The core provides state-of-the-art analysis for protein identification from mixtures of proteins; defining post-translational modifications (i.e. phosphorylation, acetylation, ubiquitination); and quantitative analysis of changes in protein expression or modification using methods such as SILAC and ITRAQ, The core works with investigators to ensure use of the best proteomic applications for design of experimental protocols needed to answer important cancer biology-related questions and provides a unique training environment for students and fellows. Highlights of proteomic research supported by the core include papers In Cell (Salmon), Nature (Zhang), PNAS (Whang) and Molecular and Cellular Biology (Burridge, Marzluff, Patterson). The core is led by three Ph.D. scientists with extensive proteomics experience: Drs. Lee Graves (Faculty Director), Maria Hines (Facility Director) and Xian Chen (Technology Development Director). Core usage has steadily increased and reflects the fundamental need to understand proteome dynamics at an ever increasing level of sophistication. The Institution and Cancer Center has provided more than $2.5 million dollars in the past five years for new mass spectrometry and nano-LC instrumentation. The core continues to increase its capacity to perform high-throughput large scale, quantitative proteomics. To accomplish these objectives, CCSG support of $144,563 is proposed, which is approximately 30% of the projected Proteomics Core operating costs for 2010. In 2009, the core was used by 46 cancer center members (100% peer-reviewed), accounting for 86% of total core usage. The proposed budget will partially support salaries of six core personnel and sen/ice contracts for mass spectrometers. This is an approximate 19% increase in CCSG support that is needed for the expansion of large scale high-throughput, quantitative proteomics. Future plans involve expanding the mass spectrometry-based infrastructure with an additional LTQ Orbitrap for support of state-of-the-art quantitative proteomics.